LAMICTAL IN TREATMENT OF MAJOR DEPRESSIVE EPISODE IN BIPOLAR DISORDER

Evaluate safety and efficacy of lamotrigine compared to placebo as monotherapy treatment for major depressive episode in adult patients with bipolar I and bioplar II disorder. Compare quality of life of patients treated with lamotrigine to those on placebo.